PHASE I CHEMOPREVENTION OF PIROXICAM AND DFMO IN PREVIOUSLY TREATED SKIN CANCER

The purpose of this project is to study piroxicam (PXM) and difluoromethylornithine (DFMO) as potential chemopreventive agents. The trial involves twelve subjects treated with PXM and then a larger number with PXM and DFMO. Measurements of ODC induction, thromboxone release and blood levels will be done.